Investigation of dopamine signaling pathways in medium spiny neurons

PROJECT SUMMARY
Schizophrenia is a mental health disorder characterized by delusions, hallucinations, disorganized speech,
and social dysfunction. It is caused by dysregulated dopamine signaling onto D2-type medium spiny neurons
(MSNs). Specifically, dopamine can be released after burst firing of the neuron, which induces phasic release.
Phasic dopamine release is elicited during reward prediction as well as in response to salient stimuli, and in
schizophrenia, phasic release is aberrantly elicited. This results in the encoding of internal stimuli as salient,
leading to the positive symptoms of schizophrenia. Nearly all antipsychotics antagonize the D2 receptor.
However, despite their wide use since the 1950s, drug discovery has been halted for the past 70 years. This is
because (1) we have limited understanding of how neurons encode phasic dopamine signaling, thereby limiting
the pathway specificity and efficacy of newly created drugs, and (2) little is known about how our current
antipsychotics change that signaling. Preliminary data in the lab has shown that upon dopamine release and
D2 receptor activation, G proteins can engage in membrane-delimited signaling or intracellular signaling with
different potencies. However, it is unknown whether these pathways are important for encoding phasic release,
and whether clinically effective and effective antipsychotics antagonize either pathway with different potencies.
This proposal addresses these two knowledge gaps by defining which postsynaptic pathways are activated by
dopamine physiologically, and how clinically effective and ineffective antipsychotics change postsynaptic
signaling in a biased manner. In Aim 1, whole cell patch-clamp electrophysiology and 2-photon imaging will be
used to define the sensitivity of membrane-delimited and intracellular signaling to dopamine in D2 MSNs. In
Aim 2 builds off Aim 1 by examining whether clinically effective and ineffective antipsychotics selectively target
these different signaling pathways. Altogether, results from the proposed experiments will allow us to define the
pathways necessary for physiologic functioning, how they change in schizophrenia, and as a result which
pathways must be targeted for effective treatment. Furthermore, completion of these aims will allow me to gain
neuropharmacology expertise, improve my technical skills in electrophysiology and 2-photon imaging, and
learn to test rigorous hypotheses applicable to my clinical interests. The training provided and skills enhanced
by this proposal will be invaluable for my becoming a psychiatrist with a focus on translating basic
neuroscience research into novel therapies for mental health disorders.

Public health relevance
PROJECT NARRATIVE Schizophrenia is a debilitating mental health disorder characterized by aberrant phasic dopamine signaling in the striatum, and effective treatment with antipsychotics is limited by knowledge gaps in dopamine physiology. There is evidence that dopamine is encoded by different postsynaptic pathways depending on the type of release, but this has never been examined in the dorsolateral striatum or in the setting of antipsychotics. This proposal aims to provide foundational knowledge for dopamine physiology and schizophrenia treatment by (1) determining how postsynaptic pathways encode phasic dopamine release, and (2) determining what postsynaptic pathways are antagonized by effective and ineffective antipsychotics upon phasic dopamine release.